Inhalable stem cell exosome therapy for cardiac injury

PROJECT SUMMARY
Myocardial infarction (MI) happens when the blood flow in one or more coronary vessels are blocked.
Due to the limited regenerative capability of the heart, this can lead to life-threatening heart failure (HF). End-
stage HF usually requires heart transplantation. Stem cells have been studied as promising therapeutics for
cardiac repair post-MI in numerous pre-clinical studies and a variety of clinical trials. However, the translation
of stem cell therapy for heart diseases from bench to bedside is still hampered by cell sources, cell viability,
uncertain delivery efficiency and immune rejection. It has been well established that many types of adult stem
cells exert their beneficial effects mainly through secretion of paracrine factors that promote endogenous heart
repair. In recent years, many in the field including our group have gravitated toward the study of extracellular
vesicles (EVs) released from stem cells, which contain the biologically active components and have
comparable therapeutic effects but minimal immunogenicity, suggesting the possibility of a promising
alternative to stem cell therapies. In the past 8 years, our group has been developing secretome and
exosomes (Exos; 30-150 nm extracellular vesicles)- based therapies for lung and heart diseases, and we have
successfully shown their therapeutic efficacy in several pre-clinical studies. Among them, transplantation of
lung spheroid cells (LSCs) has been advanced to a first-in-man clinical trial in patients with lung fibrotic disease
and LSC-secretome/exosome has recently been approved for ARDS-associated COVID-19. Given the safety
and great regenerative potential of LSC products, we performed RNA sequencing in LSC-Exos and found
various therapeutic miRNAs enriched in them. The most abundant of them, miR-100, were shown to benefit
neovascularization and heart function in several studies. However, most exosome therapies for MI treatment
have their intrinsic limitations, such as the safety and efficiency of delivery routes, deliberately hindered the
clinical feasibility. Moreover, since the half-life of Exos in vivo is short, repeated dosing of exosomes is required
for long-term heart treatment. Our main goal of current proposal is to develop inhalation delivery, as a
repeatable and noninvasive route that may boost the efficacy and translatability of LSC-Exo treatment to MI.
Aim 1. Establish the therapeutic benefits of repeated inhalation delivery of LSC-Exo in a mouse model of MI.
Aim 2. Explore and validate the mechanism of action in LSC-Exo inhalation treatment. Aim 3. Determine the
safety and efficacy of LSC-Exo inhalation treatment in a clinically-relevant porcine model of MI. The
development of inhalable cell-free therapeutics has the potential to revolutionize current regenerative medicine
practice. The results of this project, if successful, are expected to dramatically impact current treatment options
for MI patients. These studies will help validate the use of inhalable exosomes as a new therapeutic modality
for heart disease, and lay the ground for future IND-enabled human trials.

Public health relevance
PROJECT NARRATIVE Heart disease is the leading cause of death in the United States and about 875,000 Americans die from heart disease each year, of which 50-60% deaths are caused by coronary artery disease which can further develop into heart failure and scarring. We discovered a lung stem cell-derived exosome product and its cargo microRNAs that play an essential role in cardiac repair. In this grant proposal we will study the safety, efficacy, and mechanism of exosome inhalation therapy to treat ischemic heart diseases in both small and large animal models.